Mechanisms Driving the Rapid Evolution of Cancer Genomes

PROJECT SUMMARY/ABSTRACT
The goal of this proposal is to identify the mechanism of catastrophic mutational processes that drive
very rapid evolution of cancer genomes. One of these processes is chromothripsis, which involves massive
chromosome rearrangement of only one or a few chromosomes and occurs within a single cell division. My group
identified a general mechanism that explains chromothripsis. Using single cell genomics technology developed
in my laboratory (Look-Seq), we discovered that chromothripsis originates from cancer-associated aberrations
of the nucleus called micronuclei or chromosome bridges (Fig. 1, Research Strategy). These structures have
fragile nuclear envelopes that undergo spontaneous rupture, which exposes the enclosed chromosome to the
interphase cytoplasm where it undergoes a first wave of extensive DNA breakage. When the cell with the
damaged chromosome enters mitosis, this chromosome undergoes a second wave of DNA fragmentation,
coincident with a burst of mitotic DNA replication on the damaged chromosome. After the cell exits mitosis and
divides, the chromosome fragments can be segregated to one daughter cell, or the fragments can be distributed
between both daughters. Reincorporation of these fragments into daughter cell nuclei results in the formation
nuclear bodies similar, if not identical to, previously described, but poorly understood, nuclear bodies called
53BP1 bodies. Chromosome fragments in these nuclear bodies are ligated to generate chromothripsis. In
addition to generating chromothripsis, we recently discovered that chromosomes in these nuclear bodies are
subjected to chromatin and transcriptional alterations that can be heritable over many generations, suggesting
that chromosomal instability is inherently linked to instability of transcriptional states.
Despite this recent progress, many fundamental questions about the mechanism of chromothripsis
remain unclear and will be addressed in this proposal. The mechanism of chromosome fragmentation, both in
interphase and in mitosis, remains poorly understood. The 53BP1 body response is one of the least well
understood aspects of the DNA damage response in human cells. 53BP1 bodies are proposed to protect the
genome, but this has never been directly demonstrated. 53BP1 bodies accumulate DNA end joining factors,
undergo delayed DNA replication and undergo transcriptional suppression—all by unclear mechanisms and with
unclear consequences for the genome. Because of approaches we developed, including our single cell genomics
methods, we are in a unique position to attack these fundamental problems. In addition to our work on
chromothripsis, we will also exploit the technologies we developed to address the mechanism of another poorly
understood, catastrophic mutational process, common in cancer, called chromoplexy. A comprehensive
understanding of both these mutational processes is essential to understand cancer initiation and pathogenesis
and how these events vary in different cell and tumor types.

Public health relevance
PROJECT NARRATIVE Cancer genomes are shaped by mutation and chromosome rearrangement. Understanding mutational processes driving these alterations advances our understanding of how cancer develops and has potential to lead to new cancer therapies. Building on methods unique to our laboratory, we propose to elucidate the mechanisms of catastrophic mutational processes that drive very rapid evolution of cancer genomes.